Investigating beta-hairpin antimicrobial peptide membrane activity and toxicity.

Project Summary
My immediate career goals are 1) to obtain a tenure track position as a principal investigator and 2) to improve
our understanding of the structure and function of β-hairpin antimicrobial peptides to help combat antibiotic
resistant pathogens. My previous expertise, along with the career development laid out in this proposal, will
allow me to complete the proposed research strategy and achieve these two immediate goals.
New strategies and methods for antibiotic discovery are critically needed. Macrocyclic peptides are a
promising class of antibiotic because they can target sites refractory to small molecule inhibition; however, their
large size limits their ability to bypass membranes and access intracellular targets. Macrocyclic cationic
antimicrobial peptides (CAMPs) are capable of penetrating bacterial membranes, but often have associated
toxicity, making them more difficult to use clinically. A small class of CAMPs with cyclic β-hairpin structure (β-
AMPs) access intracellular targets through bacterial membrane disruption and have a wide range of associated
toxicity. Unfortunately, the rarity of this class prevents our understanding of how their amino acid sequence
dictates their antibacterial potency and mammalian cell toxicity. I have helped developed a new synthetic
macrocyclic peptide screening technique which has identified thousands of synthetic β-AMPs, expanding
sequence information and allowing us to begin analyzing how their amino acid sequence impacts their
antibacterial potency, cell membrane specificity, and ultimately their therapeutic potential.
During Phase I of this proposal, I plan to biochemically analyze a newly acquired dataset of putative β-
AMPs with diverse antibacterial potency and mammalian cell toxicity and use this data to train a machine
learning algorithm to identify sequence features promoting antibacterial specificity. The in vivo activity of lead
peptides will then be examined using the Galleria mellonella infection model. During Phase II, I will examine
how β-AMPs interact with and permeate cell membranes composed of different lipids using strains with
genetically modified lipopolysaccharide, in vitro liposome disruption assays, and ultraviolet photodissociation
mass spectrometry. This will help us understand how β-AMPs overcome traditional methods of CAMP
resistance and have an ability to selectively target bacterial cell membranes. Lastly, through modification of our
screening technique, I have generated predictive data for how over 7,000 mutational variants of one promising
natural β-AMP's amino acid sequence impacts its antimicrobial activity. I plan to evaluate the accuracy of these
predictions through biochemical evaluation of 48 of the 7,000 variants. Differences in the toxicity and
membrane specificity of this group will also be evaluated and compared to the native sequence to better
understand how certain residues impact therapeutic potential.

Public health relevance
Project Narrative Antibiotic resistant bacterial pathogens have become a leading cause of death globally and doctors are left with few remaining treatment options. To overcome this emerging threat, new antibiotics need to be developed, but few are currently in the clinical pipeline. The aim of this proposal is to better understand the function and therapeutic potential of a rare class of macrocyclic antimicrobial peptides with beta-hairpin secondary structure using high-throughput screens followed by biochemical, computational, and mechanistic analyses.